Role of Angiotensin II in Cardiogenic Shock Pathophysiology and Outcomes

This proposal describes a 5-year intensive mentoring program and research plan with the goal of developing
the principal investigator into an independent, patient-oriented clinical researcher focusing on the
pathophysiology of cardiogenic shock (CS) and its overlap with the cardiorenal syndrome. The applicant is an
advanced heart failure cardiologist with formal training through a Master of Science in Clinical Epidemiology
and is currently an Assistant Professor at the University of Utah. CS is a life-threatening complication of
myocardial infarction or heart failure with a rising incidence but persistent 30-40% in-hospital mortality. Acute
kidney injury (AKI) and pathophysiologic vasodilation are strong and consistent risk factors for CS death, but
the mechanisms linking these risk factors with CS death and with each other are poorly understood. The
central hypothesis of this proposal is that Angiotensin II (Ang II) becomes deficient in a subset of patients
with CS resulting in AKI, vasodilation, and death. This is supported by our preliminary data showing diminished
Ang II levels in CS despite excess renin and Ang I. A similar mechanism has been observed in sepsis, leading
to approval of synthetic Ang II as a treatment for vasodilatory shock, but its role in mixed CS and vasodilatory
shock is unknown. This model challenges the paradigm that RAAS activity is always increased and always
detrimental in heart failure patients, even when it is required for the regulation of peripheral vascular resistance
and maintenance of glomerular filtration in states of reduced renal blood flow, and it provides a novel and
potentially druggable pathway for the treatment of CS. The goal of this K23 is to initiate a mentored research
project and training plan to a) establish a body of evidence for Ang II deficiency as a contributor to CS death,
vasodilation, and cardiorenal pathophysiology and b) obtain training, education, experience, and data needed
to transition to independence as a patient-oriented clinical researcher. The aims of this proposal are to i) use
advanced longitudinal data analysis techniques to evaluate the dynamic association of pathophysiologic
vasodilation in CS with AKI and death, ii) show, in a prospective CS cohort study, that Ang II deficiency is
associated with CS vasodilation independent of the systemic inflammatory response, and iii) estimate the
causal effects of vasopressors on AKI and death in CS after accounting for time-varying confounding from
circulating Ang II levels using marginal structural models. A comprehensive training plan is developed to
integrate with these aims to 1) master new skills in causal inference and longitudinal data analysis, 2) gain
robust experience leading prospective multicenter research in a critical care setting, and 3) learn to analyze
cardiorenal outcomes and measure and interpret key cardiorenal biomarkers, under the guidance of mentors
expert in these methods. This K23 award will provide the resources necessary to support the Candidate’s
transition to an independent research career in an area of growing public health importance.

Public health relevance
PROJECT NARRATIVE Cardiogenic shock is a severe and increasingly common complication of heart attacks or heart failure in which the heart cannot pump enough blood to the body. It is well known that a sudden drop in blood pressure or kidney function are some of the biggest risk factors for death from cardiogenic shock, but the reasons for this are not well understood. Our study will investigate whether this heart and kidney connection in cardiogenic shock is driven by low levels of an essential blood hormone called Angiotensin II, and whether this pathway could give us new options to improve patients’ outcomes and survival from cardiogenic shock.